DEVELOPMENT OF ENZYME-LINKED IMMUNOSORBENT ASSAYS (ELISAS) FOR NINDS NIH BLUEPRINT NEUROTHERAPEUTICS (BPN) BIOLOGICS PROJECT

The National Institute of Neurological Disorders and Stroke (NINDS), via its Blueprint (BPNBiologics)
network, is funding a cooperative agreement for the development of an antibody
for treatment of Duchenne’s muscular
dystrophy (DMD). The goals of the BPN-Biologics cooperative agreement are to optimize the
lead antibody, evaluate short-term in vivo efficacy of the optimized lead
antibody(ies), complete pre-clinical studies and manufacturing, and progress the lead clinical
candidate antibody(ies) through IND-enabling studies and an IND regulatory filing. A single
down-selected lead progeny antibody with optimal characteristics will then
progress to IND-enabling in vivo and in vitro studies and to clinical trial evaluation.

Public health relevance
Development of treatments for neurological disorders; Duchenne's muscular dystrophy; antibodies